Outreach Core

PROJECT ABSTRACT/SUMMARY
The SASCO Outreach Core will serve to promote the broad use of systems biology in cancer research beyond
the University of Virginia (UVA); disseminate and increase accessibility of computational and experimental
approaches developed within the SASCO Center to the cancer research enterprise; and recruit the
involvement of investigators, cancer biologists, and clinicians from diverse backgrounds to enrich the research
and environment of the Center. The Outreach Core will pursue three initiatives. First, undergraduates from
around the country will participate in summer research experiences in SASCO laboratories through existing
outstanding summer research internship programs at the Schools of Medicine and Engineering & Applied
Science. Second, we will develop a series of three 25-minute videos designed to introduce clinicians to
systems concepts and approaches toward enabling stronger collaborations between clinicians and systems
biologists. The videos will be piloted for effectiveness within a Clinical and Translational Science Award
program that includes UVA and other health centers in the Commonwealth of Virginia. Third, the SASCO
Outreach Core will enable summer scholar-in-residence positions for faculty of historically Black colleges and
universities (HBCUs) to develop research projects in SASCO laboratories. The goal of this third aim is to both
establish systems-based research projects at HBCUs and increase the visibility of systems approaches in their
curricula. The Outreach Core synergizes with the Center’s Plan to Enhance Diverse Perspectives by engaging
individuals from historically marginalized groups at the undergraduate to faculty levels in SASCO research
themes.